Purdue Drug Discovery Training Program

Abstract
The objective of the Purdue Drug Discovery Training Program (PDD-TP) is to provide
predoctoral students with a comprehensive and balanced perspective of drug discovery and
development, and to develop a multi-disciplinary approach toward the design of novel molecular
entities with promising medicinal activity, with subsequent optimization and preclinical
evaluation. Trainees will take an integrated curriculum that expands their breadth of knowledge
and experimental approach toward the discovery of novel targets for drug development, and will
participate in a research embedding project outside their primary laboratory for further
experience and training. Trainees will also participate in program-specific activities intended to
enhance communication, critical thinking, leadership, management, mentorship, networking,
and entrepreneurism. Activities include a journal club, formal presentations of cross-disciplinary
research, organization of seminars in drug discovery, unique opportunities to engage experts in
the evaluation of drug pipeline candidates, and participation in a mock drug panel review. Every
effort will be made to maximize the diversity of training program applicants, and to recruit and
retain trainees of diverse backgrounds. PDD-TP trainees will graduate with a comprehensive
skill set and exposure to drug discovery and pipeline development, and with experiences that
will continue to serve them long after they enter the biomedical workforce.

Public health relevance
Narrative Activities in drug discovery are often disjointed, creating inaccurate perspectives on the steps required to advance drug candidates through the development process. The mission of the Purdue Drug Discovery Training Program is to provide trainees with the instruction and key experiences that will enable them to define a critical path for the synthesis, testing, and optimization of drug candidates of their own design. We propose education and training activities that strengthen the knowledge base and skill sets needed for productive drug optimization, as well as for avoiding the many pitfalls that can emerge along the development pathway.